Accelerating AF repair with a multi-factor mechanoactive patch

Intervertebral disc herniations, caused by extrusion of nucleus pulposus tissue through a defect in the annulus
fibrosus (AF), affect 2 to 3% of the world population and can be a significant contributor to back pain and
disability. The gold standard clinical treatment for patients with persistent pain from disc herniation that is
unresolved after conservative treatment is microdiscectomy surgery, during which the herniated tissue is
removed to relieve pressure on the nerve roots. However, the AF is not surgically repaired during this procedure.
Given the limited endogenous healing capacity of the AF, 10 to 30% of patients will experience a symptomatic
recurrent herniation. Due to the clinical burden of disc herniations and the absence of alternatives to discectomy,
there is a substantial need to develop and translate novel AF repair devices which can facilitate annular healing,
restore disc mechanics, and prevent re-herniation. Endogenous repair following injury is hindered by AF cell
apoptosis, increased local inflammation and ultimately the formation of disorganized scar tissue. Repair
strategies that address this complex biological milieu, while restoring AF mechanical function and preventing re-
herniation have yet to be established and proven efficacious in large animal studies. Here, we will optimize and
translate a novel tension-activated annular repair scaffold (TARS) to address both the structural and biological
requirements for annular repair. The TARS implants are composed of two layers of aligned nanofibrous polymer
scaffolds, containing depots of microcapsules between the scaffold layers which release their contents under
mechanical loading (MAMCs). When the TARS is loaded in tension, the MAMCs are compressed, leading to
release of bioactive molecules. In Aim 1, we will define the release profiles of the TARS in vitro under dynamic
uniaxial tensile loading in a physiologic environment, and in situ when affixed to the AF in cadaveric goat cervical
spine motion segments. From this Aim, we will validate a TARS design that can deliver bioactive molecules to
the repair site over acute and chronic timescales. In Aim 2, we will target the biological sequalae of annular
injury and evaluate the ability of an anti-inflammatory and pro-anabolic TARS to promote local AF repair and
global spine functional restoration in vivo in a goat cervical disc injury model. AF injury and repair will be
thoroughly evaluated across length scales, with a focus on the restoration of healthy AF structure, biology and
mechanical function. This novel and translationally relevant AF repair technology could change clinical practice
for the treatment of disc herniations, reduce the incidence of reherniation, and improve the long-term spine health
of patients.

Public health relevance
Intervertebral disc herniations affect 2 to 3% of the world population and, when severe, result in persistent pain and disability. For patients requiring microdiscectomy surgery, there are no clinically available treatments to repair the defect, resulting in increased incidence of re-herniation and progressive disc degeneration. In this proposal, we will translate a novel annular repair scaffold designed to release bioactive factors to the injury site in response to physiologic loading, controlling inflammation and stimulating cell anabolism to promote the restoration of healthy annulus structure, biology, and mechanical function.